Bioenergetic regulation of the innate immune response after TBI

Microglial/macrophage activation contributes to neuronal injury after traumatic brain injury (TBI),
primarily through release of cytokines, proteases, and reactive oxygen species. Recent studies
from our lab and others show that these aspects of microglia/macrophage activation can be
suppressed by limiting glucose flux through glycolysis. Activated microglia/macrophages are
unique among brain cells in that they primarily utilize hexokinase-2 (Hk2) rather than
hexokinase-1, thus enabling selective targeting of glycolysis in these cells. The over-riding aim
of this proposal is to determine if Hk2 inhibition can suppress pathogenic aspects of
microglial/macrophage activation and improve outcomes in a mouse model of TBI. We will
assess microglial gene expression, cytokine expression, oxidant production, and neural and
microvascular injury in transgenic mice in which Hk2 is selectively deleted in the
microglial/macrophage lineage, and in wild-type mice treated with Hk2 inhibitors at time points
after controlled cortical impact. A single Hk2 inhibitor will then be chosen for assessments of
long term histological and behavioral outcomes after TBI. We will place a particular focus on the
effects of these interventions on neurite (dendrite and axon) loss after TBI, as our findings to
date indicate inflammation to be a major determinant of neurite degeneration. In parallel, studies
using cultured microglia will assess the effects of Hk2 inhibition on overall glycolytic rate, gene
expression and pro- and anti-inflammatory processes. These studies will also evaluate a
potential mechanism by which glycolytic inhibition influences microglial/ macrophage activation.
Of note, selective Hk2 inhibitors are now entering clinical use for other purposes, thus facilitating
potential translation of these studies to clinical treatment of TBI.

Public health relevance
Traumatic brain injury triggers the activation of microglia and macrophages, as part of the innate immune response. This response is a first line defense against infection, but it also contributes to secondary brain injury. Recent findings indicate that microglial/macrophage activation can be suppressed by limiting glycolytic flux. Here we will evaluate targeted inhibition of microglial/macrophage glycolytic flux as an approach to improving outcome in a rodent model of traumatic brain injury. We will also evaluate the mechanism by which reduced glycolytic flux attenuates inflammatory responses in brain.